CORE--EQUIPMENT

Core C, the Equipment Core, is a proposal to purchase the Center for Voice and Speech two important systems: a high-performance 3-D workstation and a high-speed video system. Both of these are specified in two different projects and other investigators are looking at ways to improve the methodology of their proposed studies using these systems. Requesting these systems underscores the desire of Center investigators to apply the best available technology to these studies.